HIV and cocaine mediated lipid dysregulation in microglia: Immunometabolism mechanisms underlying NeuroHIV

Abstract
In the era of combination antiretroviral therapy, people living with HIV (PLWH) have a similar life-expectancy to
the HIV-negative population. However, the life-quality of PLWHIV is still deeply compromised due to the
prevalence of neurological symptoms (NeuroHIV). Recently, a novel subtype of Mg, called lipid-droplet-
accumulating Mg (LDAM), has been identified in both mouse and human aging brains as well as in Alzheimer’s
disease. LDAM have dysregulated lipid metabolism and are characterized by increased reactive oxygen species
(ROS) production, low levels of inflammation, and defective phagocytosis. Previous investigations have shown
that HIV infection and abused drugs could affect brain lipid metabolism which contributes to NeuroAIDS.
However, whether and how HIV/HIV proteins and abused drugs affect microglial lipid metabolism and whether
and how LDAM are involved in NeuroHIV in the context of HIV and abused drugs have never been explored. We
initiated an investigation and obtained these preliminary data : (1) HIV-TAT and cocaine individually increases
lipid droplets (LDs) formation in vitro and in vivo; (2) HIV-TAT and cocaine individually upregulates the activity
of sterol regulatory element binding proteins (SREBPs) - mediated pathway in time- and dose- dependent
manners in vitro; (3) SREBP2 inhibitor 5-O-methylembelin blocks HIV-TAT-mediated LDs formation and Mg
activation; (4) The co-exposure of cocaine and HIV-TAT exerts combined effects on Mg lipid metabolism in vitro
and in vivo; (5) HIV-inducible(i) TAT mice both show increased LDAM in the brains compared to age-matched
counterparts; (6) SIV (+) macaque brains showed increased LDAM compared to their age-matched uninfected
counterparts. Based on these preliminary data and the critical roles of LDAM in multiple neurodegenerative
diseases, we hypothesize that dysregulated lipid metabolism serves as the master mechanism responsible
for Mg activation in the context of HIV/HIV proteins and cocaine, and that targeting on LDAM could
mitigate NeuroHIV in PLWH who use cocaine. We will test this hypothesis in the following two specific aims
(SA) through complimentary in vitro and in vivo approaches: SA1: Determine the role of dysregulated lipid
metabolism in Mg activation and neuronal injuries in the context of HIV-TAT/HIV and cocaine in vitro. SA2:
Determine the potential therapeutic effects of inhibiting lipid metabolism on NeuroHIV symptoms. We will
correlate lipid dysregulation and Mg activation with neurological behaviors to validate the therapeutic effects of
targeting lipid metabolism on NeuroHIV in PLWH using cocaine.

Public health relevance
Narrative People living with HIV have comparable life-expectancy as their HIV-negative peers but their life-quality is deeply compromised due to the high prevalence of neurological disorders. Cocaine abuse could exacerbate the existing neurological disorders in PLWH. Understanding the immunometabolism mechanisms underlying Mg activation and neuronal injuries could give us clues to develop effective therapeutics and interventions NeuroHIV for chronic HIV (+) individuals who use cocaine.